Coding and Noncoding Molecular Mechanisms of a Bifunctional Gene in Multiple Cellular Contexts

PROJECT SUMMARY/ABSTRACT
Dysfunctional cellular processes contribute to the pathogenesis of many human diseases. Genes and their
functional products are central to the molecular mechanisms of all cellular processes. As such, determining the
regulation and molecular mechanisms of uncharacterized genes may reveal mechanisms controlling cellular
processes that could be exploited to improve disease.
Long noncoding RNA genes (lncRNAs) are a type of regulatory noncoding RNA that contain 200 or more
nucleotides and don’t encode proteins. They are increasingly recognized as critical cell and context specific
regulators of cellular functions. There are potentially tens of thousands of lncRNA genes; however, the function
and molecular mechanism of most are unknown. Determining these may reveal mechanisms regulating cellular
processes that could lead to more specific ways of targeting cellular defects that contribute to human disease.
LncRNAs are not supposed to code for proteins, but recent systematic analyses found an appreciable
proportion contain unrecognized small open reading frames (sORFs) that are translated into functional
microproteins of less than 100 amino acids. Some microproteins regulate key cellular processes; however, the
vast majority of putative microproteins encoded by lncRNAs remain functionally and mechanistically unvalidated.
Furthermore, some microproteins encoded by lncRNA genes exhibit functions distinct from those of their parent
lncRNAs. These “bifunctional” genes (i.e., possess coding and noncoding functional elements) are poorly
understood and pose intriguing questions about their regulation and cellular mechanisms.
Our long-term goal is to understand how bifunctional genes are regulated and how they control fundamental
cellular processes. Towards this goal, we have identified a bifunctional gene currently annotated as a lncRNA
that is mainly expressed in T cells and cortical neurons. Its microprotein-dependent effects play a crucial role in
protecting against pathogenic T cell responses, while both its microprotein-dependent and independent effects
regulate cytokine responses of T cells. However, its transcriptional and translational regulation and the molecular
mechanisms of its microprotein and lncRNA molecule are undefined. In addition, its regulation, function, and
molecular mechanism in neurons are unknown. Here, we propose using this bifunctional gene as a model and
leveraging our expertise in lncRNA and microprotein cellular and molecular biology to address the following
questions: 1) What are the transcriptional and translational mechanisms regulating its RNA and microprotein
expression? 2) What are the molecular mechanisms of its RNA molecule and microprotein? 3) How do different
cellular contexts influence the regulation of expression and the molecular mechanisms of its microprotein and
RNA products? By addressing these questions, we will establish a template for characterizing bifunctional genes
thereby enhancing understanding of this growing group of genes and their contributions to human disease.

Public health relevance
PROJECT NARRATIVE Our research focuses on determining the regulation and molecular mechanisms of bifunctional genes, which possess both coding and noncoding elements. We have identified a bifunctional gene expressed in T cells and neurons, which plays a crucial role in pathologic T cell responses and cytokine production. By investigating its transcriptional and translational regulation, as well as the molecular mechanisms of its RNA and microprotein products in multiple cellular contexts, we aim to establish a framework for characterizing bifunctional genes and elucidating their contributions to human disease.